CHANGES IN SUBSTRATE FLUX AND THERMOGENESIS WITH INTENSIVE INSULIN THERAPY

The purpose of this study is to investigate the effects of intensive insulin therapy on the disturbances of substrate and energy metabolism in poorly controlled insulin-dependent diabetes mellitus.